Accessing Carbon-based S(VI) compounds via Sulfur-Fluorine (SuFEx) Exchange Reactions

S(VI)-based compounds are a critical class of organic molecules with biomedical applications
against inflammatory disorders, cancer, and bacterial infections. Approaches to making
these carbon-based sulfur(VI) compounds are limited by the commercial availability of starting
materials and harsh reactions preventing late-stage functionalization. Sulfur-fluorine exchange
(SuFEx) chemistry is a new, promising pathway to synthesize sulfonylated products from
sulfur(VI) fluorides and nucleophiles, but the unique stability of sulfur(VI) fluorides compared to
other S(VI) halides introduces challenges for synthetic applications. We propose new (SuFEx)
reactions to make carbon-based sulfonylated compounds using metals salt and sulfur(VI)
fluorides. The proposed work is innovative because it seeks to develop attractive alternatives to
induce sulfonylated moieties into organic molecules using affordable Lewis acid catalysts and
easy-to-handle metal bases. Successful implementation of the research proposed herein will
lead to novel, one-step SuFEx transformations toward S–N and S–C formation, enabling the
development of new, diverse libraries for drug discovery. The first aim focuses on the
development of calcium-catalyzed activation of sulfonyl, sulfonimidoyl, and sulfondiimidoyl
fluorides to make sulfonamides as well as new chiral S(VI) compounds chiral bioisosteres
sulfonimidamides, and sulfondiimidamides – critically underdeveloped classes of sulfonylated
compounds with high potential as drug targets. The proposed transformations will represent a
considerable advance over current methods that rely on starting materials that are challenging
to synthesize or isolate. Additionally, these reactions would be the first Lewis acid-catalyzed
SuFEx reaction. The second aim focuses on understanding the catalytic Lewis-acid activation
mechanism of sulfur(VI) fluorides in SuFEx chemistry. These kinetic and computational studies
will provide critical information for understanding key intermolecular interactions that govern the
reaction, leading to a new generation of SuFEx reactions. The third aim will focus on developing
a two- step, one-pot method to access sulfones and sulfonate esters from sulfonyl fluorides and
fluorosulfates using metal enolates. The proposed SuFEx/decarboxylative method would
establish the role of enolates as carbon nucleophiles to sulfonylated compounds. This would
represent a new avenue in SuFEx chemistry and allow access to complex structures in sulfones
and sulfonates esters key to their promise in drug discovery. The PI’s research has enhanced the
research environment at Pomona College by engaging undergraduate students in biomedically
relevant research with a significant impact on synthesis and medicinal chemistry.

Public health relevance
Project Narrative The proposed research involves the development of new methods to introduce key structural motifs into bioactive molecules relevant to public health. Successful implementation of the work can potentially expand libraries of drug targets, thereby lowering the cost of producing pharmaceuticals. The proposed work will engage undergraduate students in synthetic chemistry research, a field broadly used in constructing molecules with broad biomedical applications.